Dissecting the Synaptic and Cellular Actions of Dopamine in Vivo

Project Summary
The neuromodulator dopamine is critical for motivating, performing, and reinforcing goal-directed behaviors, and
deficits in dopamine signaling are common in neuropsychiatric disorders like depression, obsessive-compulsive
disorder, addiction and Parkinson’s disease. Central to our understanding of dopamine function is the notion
that phasic increases and decreases in extracellular dopamine levels in the striatum modulate striatal output to
modify behavior on short and long timescales. For instance, phasic elevations in striatal dopamine elicited by
salient stimuli and reward-predicting cues have been proposed to promote arousal, facilitate action initiation and
increase motivation to work on timescales of seconds to minutes, but also to modify future actions and behavioral
decisions on longer timescales extending to days. This raises a fundamental question: How does dopamine
modulate the activity of striatal neurons to exert its influence on behavior? Experiments in vitro have
revealed a myriad of molecular targets sensitive to modulation by dopamine. However, the net effects of these
changes on striatal output in vivo remain unknown. One reason is that few methods are capable of dissecting
dopamine’s cell type-specific neuromodulatory effects on synaptic strength, somatic excitability and network
dynamics in the awake, behaving brain. This proposal aims to fill this gap in knowledge using in vivo whole-cell
electrophysiology and two-photon microscopy, focusing initially on the neuromodulatory effects occurring on
timescales of seconds to minutes. Informed by our published and preliminary data with these techniques, we
will test the hypothesis that phasic dopamine transients reflecting positive and negative reward
prediction errors promote the activation of striatal projection neurons expressing D1- and D2-type
dopamine receptors (D1-SPNs and D2-SPNs), respectively, via a combination of intrinsic and synaptic
short-term plasticity mechanisms. To do so, we will harness our ability to record sub-threshold membrane
potential dynamics in vivo to reveal how behaviorally- and optogenetically-evoked dopamine transients alter the
intrinsic excitability of D1- and D2-SPNs (Aim 1) and the potency of excitatory synapses impinging on them (Aim
2). In Aim 3, we will employ calcium imaging to uncover the short-term influence of phasic dopamine transients
on striatal output. Together, our experiments will provide crucial mechanistic insights into the modulatory actions
of dopamine in vivo, shedding light on a key link between dopamine release and behavioral modifications, and
paving the way for novel therapeutic interventions aimed at treating neuropsychiatric disorders.

Public health relevance
Project Narrative Dopamine is well-known for its importance in motivating, performing and reinforcing behavior, and its dysfunction is implicated in many neuropsychiatric diseases including depression, addiction and Parkinson’s Disease. How dopamine influences the activity of target neurons to modify behavior, however, remains unclear. Developing an understanding of dopamine’s actions on synapses, cells and circuits will help to clarify these actions and pave the way for novel targets for treatments that leverage these mechanisms.